CORE--HISTOLOGY

Each of the four projects in the SCOR will be supported by the Histology Core. The functions of the histology core will be to (1) perform in-depth analysis of mutant mouse phenotypes at the histological level, (2) characterize alterations in gene expressions in mutant mouse strains, using in situ hybridization and immunocytochemicals techniques (3) characterize alterations in gene expressions in mutant mouse strains, using in situ hybridization and immunocytochemicals techniques (3) analyze and interpret the expression patterns of lacZ transgene in wildtype and mutant mouse background. The histology core will be supervised by Dr. James Richardson at UT Southwestern.